Learning Health systems training to improve Disability and chronic condition care (LeaHD) Administrative Core

ABSTRACT: ADMINISTRATIVE CORE
The Administrative Core (AC) will catalyze and champion LeaHD’s mission, goals and activities. Specifically,
the AC will: 1) provide administrative and financial management, and coordinate interactions among
leadership, co-investigators, scientists, and mentors from affiliated universities, health systems, and community
partners; 2) develop and execute a recruitment and retention plan, solicit proposals, review applications, and
submit required regulatory documents for research projects; and 3) employ clear outcome and impact metrics
to evaluate and document LeaHD activities. The AC will establish and lead activities of the LHS Innovation Hub
of nine engaged health system partners, and serve as a point of contact for LeaHD activities. The AC will
facilitate communications with both internal and external parties. It will develop and maintain a contact
database, website, and a strong social media presence. The AC’s comprehensive plan to recruit and retain a
diverse pool of applicants for scientist positions will be enhanced through the input of a Recruitment and
Outreach Advisory Committee and will be strengthened by a Community Outreach Network of external
partners who are committed to diversity, equity, and inclusion efforts relative to the workforce serving persons
with disability and chronic conditions. The AC will develop calls for LeaHD scientists, coordinate review and
selection, and collaborate with the Research Education Core (REC) to develop a strategy for ensuring viability
of mentoring and training relationships. The AC will communicate with mentors, and finalize plans for
supporting mentoring activities. The AC and REC will work together to oversee completion of individualized
development plans and mentoring agreements. The AC will work with the Research and Data Analysis Core
(RDAC) to plan for PCOR/CER project solicitation, review, selection, and resource requirements. Finally, the
AC will implement a comprehensive program evaluation that employs clear impact metrics. The AC’s success
will be facilitated by its strong and experienced leadership, and established, effective collaborations between
PIs, co-investigators, and partner health systems institutions. Linda Resnik, PT, PhD will serve as AC Principal
Investigator. Dr. Resnik is the Director of two research and training centers, the NIH-funded Learning Health
Systems (LHS) Rehabilitation Research Resource Center (LeaRRn), and the Center on Health Services
Training and Research (CoHSTAR), funded by the Foundation for Physical Therapy Research. AC Co-
investigator Janet Freburger is the Director of LeaRRn’s Health System Innovation Hub and co-Principal
Investigator of LeaRRn’s LHS mentored Scholars. Together, Resnik and Freburger have developed
relationships and worked closely with 10 health system partners to identify research priorities, and match
dozens of LeaRRn’s LHS Scholars to health systems to develop research projects to address health system
needs. The AC will be guided by an Executive Committee that includes Resnik, Freburger, and REC PI
Theresa Shireman.